Improving the health status of dysvascular amputees by deploying digital prosthetic interface technology in combination with exercise intervention

Project Summary/Abstract
Persons with dysvascular amputations are at great risk for life-threatening cardiovascular disease. While
exercise has been shown to reduce this risk, often times dysvascular amputees are unable to perform physical
activity due to pressure lesions and sores generated by poor prosthetic socket fit. This Small Business
Innovation Research (SBIR) Phase-II project proposes the deployment of a computationally derived transtibial
prosthetic interface technology to promote adherence to a tele-health exercise intervention for persons with
dysvascular amputation. The prosthetic interface is digitally generated using a computational framework
focused on the creation of a liner and socket quantitatively derived from a biophysical model of the amputated
residuum. Previously developed at MIT and productized at Bionic Skins, this data-driven design and
manufacturing framework is based on a clear scientific rationale to maximize comfort and avoid tissue injury by
diminishing areas of high contact pressure between the residuum and interface.
The proposed SBIR Phase-II activities are sorted into four specific aims. In Aim 1, subjects with dysvascular
transtibial unilateral amputations will be recruited and be separated evenly into two groups. Data on Group 2
will be collected using Computed Tomography (CT) and detailed biomechanical models will be derived from
each scan for use in the computational framework. In Aim 2, Finite Element Analysis (FEA) will be combined
with test socket evaluations to optimize and then fabricate a definitive liner and socket for all subjects in Group
2 using the Digital Design to Digital Manufacturing pipeline. In Aim 3, initial biomechanical assessments of all
socket interfaces (digitally designed and conventional) for both cohorts will be performed using intra-socket
interface pressure measurements, thermal imaging measurements of the residuum, a socket evaluation
questionnaire, and prosthetist tissue evaluation. In Aim 4 a randomized (superiority) clinical trial will be
conducted to compare clinical outcomes over a period of 12 months in dysvascular unilateral transtibial
amputees participating in an exercise-based intervention program when using Bionic Skins’ digital prosthetic
interface technology vs. a socket that is manufactured using a traditional (artisanal) technique. The
assessments outlined in Aim 3 will be performed periodically over the twelve months to gather longitudinal
data. Significant differences between the two groups will be reported.
The long-term commercial goal of the project is to generate evidence that Bionic Skins’ computationally
personalized prosthetic interface is superior to conventional interfaces in comfort, fit, and maintenance of good
tissue health and thus a viable option to include in various exercise-related interventions for persons with
below-knee amputations, or as an everyday prosthetic interface option.

Public health relevance
Project Narrative There are an estimated 1.7 million people living with amputations in the United States today, with approximately 54% of all lower-limb amputations considered to be of dysvascular etiology. Persons with dysvascular amputation are at great risk for life-threatening cardiovascular disease but cannot perform preventative exercise routines due to pain generated by poor prosthetic interface fit. This proposal aims to utilize a computationally derived prosthetic interface technology optimized for comfort to promote adherence to a tele-health exercise intervention for persons with dysvascular amputation.